The Translational Glycomics Symposium

Project Summary
The 2024 Translational Glycomics Symposium, organized by the Translational Glycomics Center at Versiti Blood
Research Institute in Milwaukee, Wisconsin, is set for September 26-27, 2024. This annual event is dedicated
to advancing translational glycobiology and nurturing emerging researchers. The symposium's primary goals are
to give trainees and early-stage investigators opportunities to develop collaborative research and increase the
visibility of glycoscience in basic, translational, and clinical disciplines. As a complimentary event, it welcomes
diverse experts to present their findings to the broader glycoscience and clinical-translational community,
including those at the beginning of their careers. The symposium covers glycobiology related topics in aging,
inflammation, immunology, classical and malignant hematology, solid cancer, and regenerative medicine,
offered in a hybrid format for both in-person and online participants. It serves as an essential resource for
researchers and clinicians in glycoscience, offering opportunities for networking, collaboration, and learning
about the latest developments in the field. With a strong commitment to supporting trainees and early-stage
investigators, particularly from underrepresented backgrounds, the symposium ensures accessibility and
inclusivity for all attendees. The specific aims of the program are:
1. Empower Trainees and Early-Stage Investigators: Provide a dynamic platform for trainees and early-
stage investigators, particularly those from underrepresented groups, to present their research, receive
constructive feedback, and forge future collaborations, thereby nurturing the next generation of
glycoscience researchers.
2. Foster Collaborative Research in Translational Glycoscience: Create opportunities for collaboration
among glycoscience researchers, interdisciplinary researchers, and physician-scientists to enhance
research outcomes and innovations in the field.
3. Enhance Glycoscience Visibility: Highlight the significance and clinical implications of glycoscience,
encouraging its integration into broader scientific discussions and analyses.
4. Promote Specialized Training: Address the deficiency of glycoscience expertise in biomedical
institutions by offering specialized training and educational resources. Facilitate the integration of clinical
trainees into glycosciences and basic science trainees into translational medicine, ensuring the efficient
translation of novel glyco-concepts from laboratory research to enhanced patient care.
Through these aims, the Translational Glycomics Symposium aspires to be a catalyst for groundbreaking
research and transformative developments in glycoscience, ultimately contributing to improving patient care and
treatment methodologies.

Public health relevance
Project Narrative The annual Translational Glycomics Symposium, hosted by the Versiti Blood Research Institute, is a vibrant platform for trainees and young investigators to present their groundbreaking research, network with peers and seasoned experts, and foster a diverse and inclusive scientific community. This symposium brings together leading researchers from around the world, fosters collaboration, and accelerates the translation of glycoscience discoveries into clinical practice. By showcasing the transformative potential of glycoscience research, the symposium aims to propel this field to the forefront of modern medicine, ultimately paving the way for novel treatments and empowering doctors to better serve their patients.